Investigating regional and cellular vulnerabilities to tau pathology in young-onset Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Development of cognitive problems at any age is devastating, but development of cognitive problems in
working-age people with dependents represents a major public health concern. Young-onset Alzheimer's
disease (YOAD) is defined as individuals who present before age 65 and lack mutations known to cause
Alzheimer's disease (AD) pathology. Neuropathology and neuroimaging studies demonstrate greater tau
accumulation in YOAD who often present with atypical, non-amnestic syndromes. Our preliminary data
demonstrates that tau accumulation occurs through progressive maturity levels in tangle-bearing neurons,
which disproportionately affects cortical more than limbic structures in YOAD. Moreover, we show younger age
onset is associated with greater tangle accumulation and neuronal loss in nucleus basalis of Meynert
(cholinergic hub) and locus coeruleus (noradrenergic hub) – two neuromodulatory hubs implicated in early
stage of disease. As stereotypic amyloid-β plaque patterns are robustly observed regardless of age, and
comorbid neuropathologies are less frequent in YOAD, this cohort is ideally suited for a targeted investigation
of selective vulnerabilities to tangle pathology in AD. Regional vulnerabilities to advanced tangle maturity levels
in corticolimbic structures and neuromodulatory hubs are hypothesized to underlie the syndromic heterogeneity
observed in YOAD. The overall goal of this grant is to uncover signatures of regional and cellular vulnerabilities
underlying syndromic heterogeneity in YOAD by investigating what modifies patterns of tangle accumulation
and microglial activation. Our preliminary data from single-cell RNA sequencing underscores the importance of
considering disease heterogeneity and the utility of quantitative neuropathology for validating gene expression
changes. This proposal seeks to shift current research in AD by focusing on younger-aged individuals and
demonstrating how regional variability can inform cellular biology even in the context of end-stage disease. To
accomplish our goals and facilitate stratification by atypical and typical (amnestic) clinical syndromes, the MPI
team has combined expertise and resources to amass one of the largest documented YOAD cohorts totaling
558 brains with available tissue for study. The goal of the grant is to test the following hypotheses: 1)
Modifiers of the neuropathologic patterns of tau pathology in YOAD brains differ between cases stratified
by atypical vs. typical (amnestic) clinical syndromes, 2) The most vulnerable neuronal populations to AD-tau
share a similar molecular signature across corticolimbic regions reflective of syndromic heterogeneity in
YOAD, and 3) Corticolimbic microglial activation patterns differ in the brains of YOAD cases stratified by
atypical vs. typical (amnestic) clinical syndrome. Completion of this project will identify specific cell populations
vulnerable to regional AD-tau pathology and identify modifiers of microglial activation patterns corresponding to
aggressive tau accumulation in YOAD.

Public health relevance
PROJECT NARRATIVE Young-onset Alzheimer’s disease occurs in individuals who experience symptoms before the age of 65 and lack a known mutation. Using advanced neuropathology and transcriptomics technology, we seek to investigate why younger individuals suffer more significant accumulation of tau in neurons and more commonly report non-memory symptoms. Our scientific team has combined one of the largest series of young-onset Alzheimer’s disease brains to study, which will be critical for our evaluation of why certain brain regions and specific cells are vulnerable to changes in Alzheimer’s disease.